Developing a Shared Decision-Making Support Tool to Promote Evidence-based Treatment for Veterans with Post-concussive Sleep Conditions

Background: Veterans with mild traumatic brain injury (mTBI) are at high risk for sleep conditions (insomnia;
obstructive sleep apnea [OSA]), which disrupt sleep quality and undermine recovery. Identifying and treating
such sleep conditions using the VA/DoD clinical practice guideline (CPG) for the management of insomnia and
OSA (Sleep CPG) can produce wide-ranging benefits for Veterans’ post-concussive recovery.
Significance: The Sleep CPG specifies an evidence-based workflow for management of sleep conditions,
including: 1) screening for sleep problems; 2) assessing for sleep conditions; and, 3) delivering evidence-
based treatments. Further, the Sleep CPG includes a recommendation that Veterans and providers collaborate
to select empirically supported treatments to ensure that care aligns with Veterans’ preferences (i.e., Veteran-
centered care). However, there exists variability in Veterans’ receipt of guideline-concordant care (GCC) for
post-concussive sleep conditions due in part to: 1) lack of access to guideline-recommended practices at the
point-of-care (PoC); and, 2) challenges associated with facilitating Veteran-centered care due to the highly
individualized nature of Veterans’ preferences. Implementation strategies can enable GCC and facilitate
Veterans’ recovery by providing: 1) Veterans and providers with information regarding guideline-recommended
practices at the PoC; and, 2) structured support to facilitate Veteran-centered care. However, such strategies
have yet to be widely developed or implemented. The proposed project will address this gap in rehabilitative
care for those with mTBI and sleep conditions by developing a decision support system. The system will be
comprised of two complementary tools. First, it will include a clinical dashboard that distills patient-level data
into actionable information at the PoC, providing decision support with respect to: 1) screening for sleep
problems; 2) assessments to detect insomnia and/or OSA; and, 3) recommending guideline-concordant
treatment options based on clinical presentation. Second, a decision aid will facilitate collaboration between
providers and Veterans to promote selection of guideline-concordant treatment recommendations that align
with patients’ personal preferences. This will be accomplished by providing Veterans with necessary
information and assisting them with clarifying their priorities for intervention. The proposed system will be the
first to offer decision support across the continuum of GCC, from screening for sleep problems to Veteran-
centered treatment of identified conditions.
Specific Aims and Methodology: In Aim 1, we will use semi-structured interviews with Veterans, providers,
and policymakers to identify barriers and facilitators to evidence-based, Veteran-centered management of
post-concussive sleep conditions. In Aim 2, we will leverage stakeholder input from Aim 1 to develop a
decision support system (i.e., dashboard, decision aid) and training materials. We will also use manual chart
review to validate the accuracy with which the clinical dashboard provides actionable information to Veterans
and providers at the point-of-care. In Aim 3, we will evaluate stakeholder feedback to assess the feasibility and
acceptability of the decision support system and associated training materials. After presenting components to
stakeholders (e.g., Veterans); we will use a mixed-methods design to elicit feedback and use that feedback to
refine the prototype and materials until feasibility and acceptability criteria are met.
Deliverables from this proposed project include a feasible, acceptable, and validated support tool
capable of ensuring that Veterans with post-concussive sleep conditions receive evidence-based, Veteran-
centered care. Findings will enable a subsequent application for a VA RR&D Merit IIR that examines the
effectiveness of the decision support system on Veterans’ receipt of quality care and their functional
recovery.

Public health relevance
Veterans with mild traumatic brain injury (mTBI) are at risk for sleep conditions such as insomnia and obstructive sleep apnea (OSA), which disrupt their post-concussive recovery and undermine their quality of life. The VA/DoD Clinical Practice Guideline (CPG) for insomnia and OSA outlines best practices for identifying and treating these conditions. This includes collaborating with Veterans to select an empirically supported intervention (i.e., Veteran-centered care). However, barriers exist to Veterans’ receipt of such guideline- concordant care (GCC) for post-concussive sleep conditions. This project involves developing a tool that supports Veterans and providers in achieving GCC through: 1) identifying sleep problems; 2) recommending guideline-concordant assessment and treatment strategies; and, 3) supporting Veteran-centered treatment selection. By enabling evidence-based and Veteran-centered rehabilitative care, this tool can foster the recovery of Veterans with post-concussive sleep conditions.